MicroRNA-31 regulates neutrophil migration and activation

PROJECT SUMMARY
Neutrophils are white blood cells involved in the innate immune response. They are the
most abundant white blood cell in circulation and are involved in fighting infections as well
as initiating inflammatory immune responses and contribute to certain autoimmune
diseases. Therefore, regulation of neutrophil activity is crucial in maintaining homeostasis
in the immune system. Yet the specific mechanisms or which molecules are involved in
regulating neutrophil functions are still not fully understood. Previous studies in our lab
discovered microRNA-31 (miR-31) neutrophil motility in zebrafish. In this study we
propose to validate the function of miR-31 in human and uncover the underlying molecular
mechanism. We propose to discover key target genes of miR-31 that are important in
regulating neutrophil migration. Through a small-scale genetic screen using the
neutrophil-specific CRISPR/Cas9-based gene inactivation technique, I identified a
specific target gene of miR-31, efnb2b, involved in regulating neutrophil motility. Efnb2b
is a ligand for Eph receptors important for heart morphogenesis and angiogenesis via
regulation of cell adhesion and cell migration but not characterized in the immune system.
We propose to understand the signaling pathway regulated by efnb2 in neutrophils.
Completion of the proposed study will advance our understanding of neutrophils and
innate immunity, leading to possible therapeutic developments for neutrophil-related
diseases.

Public health relevance
PROJECT NARRATIVE Multiple microRNAs (miRNAs) have been identified as key modulators of neutrophils. In our study, we will uncover which specific genes in miR-31 are involved in neutrophil motility. The innovative knowledge obtained from this study will provide new information on mechanisms that regulate neutrophil motility and lead to possible treatments for inflammation related diseases.